Core 1: Functional Genomics and Proteomics

CCMI v2.0
Core 1: Functional Genomics and Proteomics Core
Core Lead: Nevan Krogan; Co-Investigator: Prashant Mali
SUMMARY
Systematic characterization of protein-protein interactions (PPIs) and genetic interaction networks of cancer
drivers is critical for the identification of functional complexes for patient stratification and targeted cancer
therapies. Proteomic approaches that determine PPIs and protein complex stoichiometry and topology can
provide strategic insight into the dynamic cancer landscape and help guide tailored genetic screens to assess
functional relevance of newly characterized PPIs. The Functional Genomics and Proteomics Core (Core 1)
will provide the infrastructure and technical expertise essential to the completion of the overall CCMI objectives.
With support of two Core facilities, the Functional Genomics and Proteomics Core will provide its expertise
in CRISPR genetic screens (Institute for Genomic Medicine (IGM) Genomics Center, UCSD) and proteomic
technologies (Thermo Fisher Scientific Proteomics Facility for Disease Target Discovery, UCSF, Quantitative
Biosciences Institute (QBI), Gladstone Institute) for the generation of high-quality protein-protein (Aim 2; in
support of Project 1) and genetic (Aim 1; in support of Project 2) interaction data, which will be integrated using
systems biology approaches in Project 3 and Core 2. Our goal is to provide functional and structural
characterization of cancer driver networks, model their functional interactions in three different cancers (breast,
head and neck, lung cancer), and determine consequences of introducing point mutations. Finally, we will use a
unique platform for Endogenous Network/Dynamic Structure (EN/DS) determination (Aim 3) that will use
CRISPR-based genetics to introduce point mutations and FLAG-affinity tags into the endogenous loci of selected
genes to study endogenous protein complex stoichiometry and structure using mass spectrometry and cryo-EM
(in support of Project 1).